TERTULIAS: Addressing Social Isolation to Reduce Depression Among Female Mexican Immigrants

PROJECT SUMMARY
Overview. We will conduct a randomized controlled trial of TERTULIAS, an innovative social isolation support
group model, with 240 female Mexican immigrants (FMIs) to contribute to the science of a holistic, multi-level
(individual, family, and group) intervention to reduce immigrant health disparities related to social isolation and
depression. Our transdisciplinary team will use a rigorous, mixed-method, community-engaged approach that
includes a cutting-edge biological assessment of hair cortisol as a biomarker for chronic stress.
Research Aims. 1.) To measure whether a culturally situated peer group intervention will reduce depression
and stress associated with the experience of immigration. 2.) To test whether an intervention using a “women’s
funds of knowledge” approach results in improved resilience, knowledge and empowerment. 3.) To investigate
whether a culturally situated peer group intervention using a women’s funds of knowledge approach can give
participants’ a sense and experience of social and physical connection (“emplacement”) that is lost in the
process of immigration.
Approach. We will gather survey data for domains of interest using validated instruments. Interpretation of
quantitative results will be supported by triangulation with the qualitative analysis of data sets that include
observational notes, meeting logs, and transcripts from interviews and group sessions.
Expected Outcomes. We will demonstrate a strategy for reducing health disparities related to social isolation
produced in the process of immigration. Our novel intervention will address social isolation-related health
disparities for FMIs by leveraging positive cultural dynamics and women’s funds of knowledge to nurture
transformative social connectedness, knowledge, and resiliency factors in the lives of participants.
Long-term Impact. The long-term impact of this work will be to contribute to developing a culturally and
contextually situated health promotion model for reducing health disparities in the immigrant community.
Broader Significance. In line with the NIMHD Research Framework, the proposed research will build scientific
knowledge toward solutions to health disparities that operate in multiple domains and at multiple levels of
influence. This study goes beyond identifying that health disparities exist to discover a creative health science
solution and intervention. Per our theoretical architecture that integrates theories of cultural situatedness, funds
of knowledge, and gendered emplacement, this study will demonstrate that an innovative, holistic, multi-level,
community-engaged approach can be successful without a large expenditure of financial resources, extensive
institutional infrastructure, or high-cost medically trained professional staff. This trial of TERTULIAS will create
a replicable, scalable model for culturally appropriate health promotion with FMIs that has implications for
health promotion work with other women from recent and first generation immigrant populations.

Public health relevance
PROJECT NARRATIVE We will conduct a randomized controlled trial of TERTULIAS with 240 female Mexican immigrants (FMIs) to contribute to the science of a holistic, multi-level (individual, family, and group) intervention to reduce immigrant health disparities related to social isolation and depression. Our transdisciplinary team will use a rigorous, mixed-method, community-engaged approach that includes a cutting-edge biological assessment of hair cortisol as a biomarker for chronic stress. We will gather survey data for domains of interest using validated instruments and interpretation of quantitative results will be supported by triangulation the qualitative analysis of data sets that include observational notes, meeting logs, and transcripts from interviews and group sessions.